Targeting the Sirt-1 pathway to modulate inflammation during murine Kawasaki Disease vasculitis

PROJECT ABSTRACT
Kawasaki disease (KD), the leading cause of acquired heart disease among children in the US, is an acute
febrile illness and systemic vasculitis believed to be of infectious etiology that causes coronary artery aneurysms
and can result in long-term cardiovascular sequelae. Coronary artery aneurysms develop in 25% of untreated
KD children, leading to ischemic heart disease and myocardial infarction. While intravenous immunoglobulin
(IVIG) treatment lowers this rate to 5%, up to 20% of KD patients are IVIG-resistant and have a greater risk for
coronary inflammation. A better understanding of the immune and pathological mechanisms leading to the
development of KD vasculitis is needed to identify more efficacious KD therapeutics and prevent the long-term
cardiovascular sequelae stemming from tissue inflammation and coronary remodeling. In preliminary studies
using a murine model of KD vasculitis, we discovered that genes related to inflammatory responses and IL-1
signaling are upregulated in the inflamed abdominal aorta. In addition, expression of Sirtuin 1 (SIRT1), a histone
deacetylase known for its cardioprotective functions, was decreased in the inflamed abdominal aorta of mice
during KD vasculitis. Therefore, the central hypothesis of this R01 application is that SIRT1 plays a critical role
in preventing bacterial ligand-induced IL-1β-driven vasculitis by promoting autophagy/mitophagy, which
impairs NLRP3 inflammasome activation and IL-1β production. To test this hypothesis, we will complete the
following specific aims: 1) Determine the expression pattern of SIRT1 and its role in bacterial ligand-
induced KD vasculitis and 2) Determine the mechanism by which SIRT1 activity modulates LCWE-
induced KD vasculitis. This proposal has a very high translational potential and will determine if compounds
known to activate and increase SIRT1 activity will improve or reduce cardiovascular pathology of KD. Importantly,
these studies will not only shed light on how SIRT1 influences the inflammatory response during the KD acute
phase but will also provide insight into the potential of SIRT1 modulation as a therapeutic intervention to prevent
long-term KD cardiovascular complications. Moreover, given the established role of IL-1 signaling in
atherosclerosis, our findings may illuminate novel therapeutic directions for a broad range of cardiovascular
diseases.

Public health relevance
PROJECT NARRATIVE Bacterial ligand-induced murine vasculitis, coronary arteritis and myocarditis is highly dependent of NLRP3 inflammasome activation and bioactive IL-1β release. Here, we will characterize the immune cells infiltrating the inflamed tissues and investigate how the modulation of Sirtuin-1 activity could prevent the vascular innate immune responses leading to vascular inflammation and injury. We will also decipher the immune mechanisms by which Sirtuin-1 may lessen the inflammatory response by blocking the NLRP3 inflammasome response and the autophagy/mitophagy axis.